Radical SAM Enzymes: Molecular Mechanisms of Radical Initiation

Radical SAM is one of the largest enzyme superfamilies known, with its members catalyzing a
remarkable diversity of reactions in all domains of life. Radical SAM enzymes are involved in the
synthesis of essential cofactors and antibiotics, repair of DNA damage, and the assembly of complex
biological metal clusters, among many other reactions. The presence of radical SAM enzymes in humans
as well as in both beneficial and pathogenic microbes lends high significance to understanding their
fundamental properties and mechanisms. The proposed research will develop a critical understanding of
radical SAM mechanisms, in particular the radical initiation process common to all enzymes in this large
and diverse superfamily. Research efforts will focus on trapping radical intermediates using rapid freeze-
quench, cryoreduction, annealing, and photolysis approaches. These intermediates will then be
characterized by using spectroscopic approaches such as electron paramagnetic resonance and electron-
nuclear double resonance, and structural approaches such as X-ray crystallography. Computational
studies will provide insights into stability/reactivity and reaction pathways. Much of the work will build
on the recent discovery of a novel organometallic intermediate containing a direct bond between an iron
of the iron-sulfur cluster and a carbon of an adenosyl moiety, a structure reminiscent of coenzyme B12.
The results will provide an understanding of this fundamental and ubiquitous reaction in biology, and its
surprising involvement of organometallic chemistry.

Public health relevance
The goal of this project is to elucidate the fundamental chemical underpinnings of radical SAM enzyme reactions. Radical SAM enzymes are remarkable biological catalysts that carry out difficult and unusual chemical reactions; their presence in humans as well as in both beneficial and pathogenic microbes lends high significance to understanding their fundamental properties and mechanisms. With better mechanistic understanding, these enzymes could serve as pharmaceutical targets to treat infections and/or disease, given their important but often distinct functions in humans and microbes.